Novel Therapy for Sarcopenia

Novel Therapy for Sarcopenia
Abstract
Sarcopenia, characterized by loss of skeletal muscle mass, quality, and strength, is a common hallmark of
ageing affecting 5-13% of 60-70 year-old individuals, increasing to 11-50% of those aged 80 and above (von
Haehling, 2010).
Obese and diabetic patients are at increased risk as these conditions greatly aggravate the
metabolic disturbance underlying the muscle wasting (Arnold, 2024). Preclinical and clinical studies have shown
differential impacts of anti-diabetic drugs on skeletal muscle mass, strength, and performance. The meta-
analysis of Ida et al. (2021) [18 randomized controlled trials (1,363 subjects)] found that the fat-free mass (FFM)
[as an alternative index of muscle mass], was significantly reduced by semaglutide, dapagliflozin, and
canagliflozin when compared to metformin or placebo. Thus, not unexpectedly, the recent enthusiastic and
widespread acceptance of GLP-1-based therapies for obesity has witnessed a major uptick in therapy-induced
sarcopenia: weight reduction affects both adipose as well as muscle tissue (Zhang, 2021; Arnold, 2024). Our
proposed therapy, based on a novel adipokine, isthmin 1 (Ism1), addresses the pathogenesis of these
metabolic syndromes while preserving muscle function. Ism1 plays a crucial role in the modulation of
glucose uptake in both adipocytes and muscle cells. Ism1 promotes protein synthesis in muscle, executing this
critical function by activating the PI3K/AKT/S6 pathway while suppressing protein degradation pathways. This
regulation of proteostasis prevents and reverses age-related cellular changes, including sarcopenia/muscle
atrophy. Presently, the short half-life (minutes) of Ism1 limits its clinical application. To address this issue, we
will generate a panel of longer lived versions, rank order their activity in vitro followed by proof-of-concept studies
in a rodent model of sarcopenic obesity. We anticipate that the outcome of this work will generate a muscle-
sparing therapy for age-related sarcopenia as well as the sarcopenia that complicates diabetes and obesity.
However, for efficient commercialization and clinical development, we will initially focus our efforts on sarcopenic
obesity.

Public health relevance
Narrative Sarcopenia, characterized by loss of skeletal muscle mass, quality, and strength, is a common hallmark of ageing affecting 5-13% of 60-70 year-old individuals increasing to 11-50% of those aged 80 and above. Treatment options for this major unmet need are limited. We have identified a novel protein that prevents and reverses age-related muscle cellular changes, including sarcopenia/muscle atrophy. This therapy will provide a first-in-class therapy to address sarcopenia associated with aging, diabetes and obesity.